Georgia Clinical & Translational Science Alliance (Georgia CTSA)

The Georgia Clinical and Translational Science Alliance (GaCTSA) is a compelling partnership of Emory University, Morehouse School of Medicine, the Georgia Institute of Technology and the University of Georgia, a new academic member adding resources and assets to our CTSA. Also key to GaCTSA are our healthcare partners: Emory Healthcare, Morehouse Healthcare, Children’s Healthcare of Atlanta, the Atlanta VA Medical Center, the Grady Health System, and the Atlanta Community Physicians Network and our translational science partners including the Emory National Primate Research Center (located at Emory), the Georgia Research Alliance, Georgia Bio and links to the Prevention Research Centers of the US Centers for Disease Control and Prevention (CDC). Built over the past decade of collaboration, the partners of GaCTSA have forged strong research networks and GaCTSA has become a “24 hour” home and catalyst for innovative, high quality clinical and translational research with local, national and global impact. The addition of UGA allows the GaCTSA to better serve the entire state and adds new resources, including: outstanding translational research in glycobiology, infectious diseases, One Health, a new clinical and translational research unit, outstanding programs in Education, a School of Pharmacy; a robust extension service that reaches beyond its original agricultural mission to focus on the health of the citizens of Georgia; and the Archway Partnership whose mission is to connect with Georgia communities. In the next funding cycle, GaCTSA will continue to support investigator-led translational research by improving operational efficiencies, advancing informatics infrastructure, streamlining regulatory and methodological processes, and supporting team science with an emphasis on predictive and quality-driven outcomes. GaCTSA will prioritize broad institutional participation and resource sharing to ensure that biomedical research reaches wider populations across Georgia’s varied geographic areas. The Alliance’s guiding goals align with the vision of the NCATS Advisory Council Working Group and build on the recommendations from the 2013 IOM CTSA program review. The GaCTSA’s specific aims will serve as guiding principles to drive the vision and approach.

Public health relevance
Created in response to the NIH CTSA program, the Georgia Clinical & Translational Science Alliance (Georgia CTSA) supports high quality collaborative translational science locally, regionally, and nationally; fosters scientific and operational innovation to improve the efficiency and effectiveness of clinical and translational research; and creates, provides, and disseminates domain-specific translational science training and workforce development.